The Population Research Institute

Project Summary: Population Research Institute
The Population Research Institute at the Pennsylvania State University (PRI) is a vibrant, interdisciplinary
center providing strategic resources to support innovative, high impact population dynamics research. PRI’s
overarching aim is to advance the scientific understanding of human population dynamics and processes, with
a focus on PRI’s primary research areas. First, through research on communities, neighborhoods and spatial
processes, PRI is contributing to our understanding of human population distribution across neighborhoods
and communities, the social processes that bring about these spatial patterns, and their consequences for the
health and wellbeing of individuals, families and children. Second, PRI scholarship increases knowledge of the
causes and consequences of migration and immigrant integration for health and health disparities across the
life course and generations. Third, PRI researchers address how families and social networks critically mediate
broader social change and social institutions and contribute to observed disparities between advantaged and
marginalized groups. Research assesses the structural and social barriers that prevent families from
supporting children’s health and well-being. Fourth, PRI supports research in population health with a focus on
the social determinants of maternal, child and adolescent morbidity and the important interactions between
biological factors and external environments on later development and health. PRI has historical strengths in
these areas and benefits from its institutional environment at the Pennsylvania State University that
encourages interdisciplinary population research excellence through generous financial and infrastructure
support. Through innovation and investment, PRI plans for integration and cross-collaboration across its
primary research areas in the next five years. PRI will accomplish this through its additional specific aims. First,
PRI aims to develop new leaders in population science, particularly the emerging leaders among junior
scholars. With a successful track record as an incubator of population research, PRI’s Development core will
provide additional mentoring and support for junior scholars and new opportunities designed to build
competitiveness for peer-reviewed external funding and increased impact of population science. Second, PRI
aims to foster novel approaches and methods that will make important and cutting-edge contributions to
population research through its Computational and Spatial Analysis core. Third, PRI’s Administrative core aims
to increase research productivity and collaboration, reducing the barriers and burdens associated with
research administration, and increasing the reach of population science.

Public health relevance
Project Narrative: Population Research Institute The Population Research Institute (PRI) at the Pennsylvania State University provides services and activities designed to promote the interdisciplinary study of population dynamics and improve understanding of the conditions needed to support healthy developmental trajectories from early childhood into adulthood. The population science research supported by this award will inform interventions and policies designed to reduce health disparities and improve healthy lifespan development.